The Impact of Systemic Immunosuppression on RSV Antibody Generation and Effector Functions After Vaccination

PROJECT SUMMARY
Immunosuppressed persons (ISPs) have a nearly 40% risk of hospitalization if infected with respiratory
syncytial virus (RSV). Recently, novel RSV vaccines based on the prefusion F protein of the virus were found
to be effective at reducing RSV disease, but these were not tested in high-risk ISPs. Owing to
immunosuppression, ISPs often develop attenuated antibody responses to vaccines and require either
additional doses or different formulations to achieve protective levels of antibodies. Antibodies against
prefusion F are associated with protection from RSV disease and thought to be central to the protection
afforded by RSV vaccines. Our preliminary data indicate that, among ISPs, the antibody response to RSV
vaccines is heterogeneous, with many ISPs demonstrating minimal or no response. However, the nature of this
decreased response (i.e. unrecognized antibody epitopes and impact on neutralizing and non-neutralizing
functions) remains unknown. Furthermore, the influence of specific immunosuppressive medications and the
type of vaccine received (adjuvanted vs. unadjuvanted) is undetermined. To protect this high-risk group from
this common and often devastating infection, a comprehensive understanding of the antibody response to
these vaccines by ISPs is necessary and will improve vaccine recommendations, design, and medication
management. The proposed research will address these uncertainties by systematically studying the antibody
response to novel RSV vaccines in a national observational cohort of ISPs, comparing the responses to those
of healthy participants (HPs). This national cohort of highly engaged ISPs was critical in our previous
successful efforts to define the effects of immunosuppression on SARS-CoV-2 vaccination, and we will
leverage this opportunity to discern the impact of immunosuppression on antibody responses to RSV vaccines.
We will accomplish this by quantifying the prefusion F and neutralizing antibody response longitudinally in
these groups and determining the impact of vaccine type (adjuvanted vs. unadjuvanted), type of
immunosuppressive medication, and demographic factors (Aim 1). Additionally, we will study the entire viral
antibody epitope landscape before and after vaccination using innovative DNA barcoded-protein technology to
identify key gaps in epitope recognition, measure the impact of pre-existing immunity on vaccine responses,
and correlate specific epitope responses with antibody function (Aim 2). Finally, the researchers will measure
the effect of immunosuppression and vaccine adjuvant on antibody subtype, subclass, and non-neutralizing
functions using a systems serology approach (Aim 3). The investigators’ established productive collaborative
relationships, extensive experience studying antibody responses in high-risk and/or immunosuppressed
populations, and this cohort of ISPs provide the ideal circumstances to provide critical knowledge that
promises to be directly applicable to improving RSV vaccine responses in this high-risk group and inform future
vaccine design for immunosuppressed persons.

Public health relevance
PROJECT NARRATIVE Immunosuppressed persons (ISPs) are at high-risk for hospitalization if infected with respiratory syncytial virus (RSV) and the new RSV vaccines were not studied in ISPs even though they often do not respond to vaccines as well as healthy people. By measuring and characterizing the antibody response to RSV vaccines in ISPs we will understand the factors associated with a poor response to RSV vaccines and be able to improve vaccine design and recommendations in this high-risk group of people.